Model-Based Investigation of Aberrant Neural Face Representation in Autism

Project Summary
Faces often convey a wealth of information and processing the human face is at the focal point of most social
interactions. When we see a person's face, we can easily recognize their unique identity and general features
such as race, gender, and age. The gestalt of facial processing enables us to make judgments about a
person's mood or other aspects such as their level of trustworthiness. Yet, this simple perceptual task is difﬁcult
for individuals with autism spectrum disorder (ASD), a population that spends limited amounts of time engaged
in face-to-face eye contact or social interactions in general. Although there is a large body of literature on face
perception and many studies have documented abnormal face processing in people with ASD, most existing
studies focus on the recognition of faces and emotional expressions or on perception of a particular social
attribute (e.g., trustworthiness). It remains largely unclear how the brain represents and evaluates faces in
general, and whether/how this mechanism differs in ASD. The study of face processing in ASD is very
important because it will not only help us understand the social deﬁcits of this disorder but also provide a
unique opportunity to study the factors related to the functional specialization of normal face processing.
In this project, we propose to conduct one of the very ﬁrst studies to investigate neural face
representation in individuals with ASD and delineate those brain regions involved in coding facial features.
Importantly, by using concurrent functional magnetic resonance imaging (fMRI) and eye tracking and taking
advantage of recent advances in deep neural networks (DNNs), we are able to extract association-based
features from any face and synthesize new faces for validating model predictions. The primary objectives of
this research are two-fold: (1) to establish a general neural representation of faces by constructing and
validating neural face models, and (2) to compare neural representations of faces between people with ASD
and controls. The collaboration between cognitive neuroscience and computer science in this project provides
a unique opportunity to better understand how individuals with ASD perceive human faces, speciﬁcally what
brain mechanisms are involved in representing faces in general. Obtaining this level of understanding of the
neural computational underpinnings of face representation will be unique to our understanding of face
processing in controls without ASD as well as those with ASD. In turn, this research may provide insights into
the developmental trajectory of this pervasive deﬁcit in autism and potential targets for intervention.

Public health relevance
Project Narrative The difﬁculties faced by individuals with autism to recognize the faces of others and read emotional and social cues from facial expressions can pose signiﬁcant challenges that negatively impact their quality of life by increasing anxiety and furthering social isolation. This study aims to use functional neuroimaging to investigate the underlying neural mechanisms of facial processing in individuals with autism to ascertain the precise contribution of the face processing regions to this core deﬁcit by combining the latest engineering modeling techniques and cognitive neuroscience. Our goal is to elucidate aberrant functional brain mechanisms that may underly facial processing differences and identify how this information may contribute to our understanding of the trajectory of autism, potentially add to autism screening criteria, and facilitate reﬁnement of interventions.